Translational Immunology Training Program

Project Summary/Abstract
This is a competitive renewal T32 application from the Icahn School of Medicine at Mount Sinai (ISMMS),
concentrating on pre- and post-doctoral training program in Translational Immunology by D Bogunovic and S
Lira - Co-PDs. Our training program will continue to a) enhance translational immunology training through
comprehensive exposures and cross disciplinary trainings b) leverage faculty and institutional resources, as well
as a immunology-focused infrastructure (including education, career development and evaluation processes) to
further enhance the efficiency of the training experience. Our success over the past 20 years in attracting and
training pre- and post-doctoral MD, PhD and MD/PhD trainees into immunology research careers is testament
to our dedication. Furthermore 1) there is the continued need for improving outcomes of immune-mediated
diseases 2) our desire to positively impact the education of future basic and translational investigators in
immunology, and 3) the fact that our training environment and research foci are well-suited to offer diverse basic
and translational immunology research opportunities for trainees. The exceptional ability of Mount Sinai's
immunology community to make fundamental discoveries, to translate the results into novel and effective
diagnostic and therapeutic strategies, and to incorporate pre- and post-doc training into its research mission
underscores the significance of this training program. The overall objective of this program is to attract and
train talented MD/PhD and PhD students and post-docs over 2 year periods, for successful, independent careers
in immunology relevant to human disease. We have a diverse, well-funded faculty with broad interest in
immunology and a strong pool of pre- and post-doc trainees that includes significant numbers of
underrepresented in science. The program is designed to provide training by individual mentors performing
research in all aspects of immunology relevant to human disease. The program is supported with strong oversight
and administrative structure, significant didactic training in immunology, scientific writing and career
development, and contains newly added state of the art evaluation approaches with defined goals and
benchmarks for success.

Public health relevance
Project Narrative This renewal pre- and post-doctoral training program in translational Immunology will continue to attract pre- doctoral PhD and MD/PhD as well as post-doctoral MD, PhD and MD/PhD candidates into a comprehensive training environment to teach them cutting edge immunology relevant to human disease inclusive of but not limited to autoimmune disease, allergies, immunodeficiencies, cancer, and transplantation.